Mechanism of stathmin-2-dependent axon maintenance, regeneration, and function

Abnormal nuclear depletion and cytoplasmic accumulation of the RNA-binding protein TDP-43, is reported in a
large spectrum of age-dependent neurodegenerative conditions referred as TDP-43 proteinopathies that
include almost all instances of amyotrophic lateral sclerosis (ALS), >40% of frontal temporal dementia (FTD), up
to 50% of Alzheimer's disease (AD) and elderly patients with an AD-like dementia named limbic-predominant
age-related TDP-43 encephalopathy (LATE). TDP-43 is an essential protein involved in fundamental processing
activities in the thousands of RNA transcripts to which it binds, regulating expression, splicing, and transport. We
discovered that the human mRNA most affected by reduced TDP-43 function encodes the neuron-specific protein
stathmin-2 (encoded by the STMN2 gene) whose loss is now recognized as a pathological hallmark in all
patients with TDP-43 proteinopathy. TDP-43 is required to prevent the inclusion of a cryptic exon within the first
intron of STMN2 pre-mRNA. We determined that TDP-43 binding sterically blocks STMN2 pre-mRNA
misprocessing, preventing its cryptic splicing and truncation. We also demonstrated that antisense
oligonucleotides (ASOs) can restore normal stathmin-2 levels in the nervous system upon TDP-43 dysfunction.
We recently showed that chronic focal loss of stathmin-2 from the mammalian adult lumbar spinal cord is
sufficient to drive the earliest clinical signs of ALS, including progressive muscle denervation and
neurofilament-dependent axonal collapse. Stathmin-2 has been proposed to regulate microtubule dynamics
through a "stathmin-like domain" which binds two a/b-tubulin heterodimers in a phosphorylation-dependent
manner. In cultured human neurons, stathmin-2 is required for regeneration after an initial injury by axotomy,
with elevated protein levels in regenerating neurons, axons, and growth cones. Here we seek continuing support
for a comprehensive investigation into the role of stathmin-2 in axonal maintenance and regeneration using
human induced pluripotent stem cell-derived neurons and mouse models. We will determine the mechanism(s)
through which stathmin-2 (and its partner proteins that we will identify) mediate maintenance of neuromuscular
junctions, axonal structure, and regeneration in the adult nervous system. We will assess whether tubulin and
membrane binding capabilities of stathmin-2 are necessary for axonal functionality in human neurons, determine
the impact of sustained suppression of stathmin-2 on axonal structure and synaptic function within the brain, and
establish the feasibility of stathmin-2 gene replacement strategies.

Public health relevance
Aggregation of the RNA binding protein TDP-43 and the accompanying loss of TDP-43 function is found in almost every age-dependent neurodegenerative disease, including the major dementias. Loss of TDP-43 in turn provokes an even larger loss of stathmin-2, an abundant neuronal protein required for maintenance of the processes (called axons) that neurons use to send signals to other neurons or non-neuronal cells (including muscle) and for neuronal recovery after injury. We propose to determine the mechanisms through which stathmin-2 (and its partner proteins that we will identify) mediate maintenance of axonal structure and regeneration in the adult nervous system and the feasibility of gene replacement strategies.